IMURAN THERAPY IN LONGTERM RENAL TRANSPLANT PATIENTS

The purpose of this study is to document the experience of the Division of Nephrology with the effect of tapering Imuran doses over the years on transplant outcome. This is a retrospective study to test the hypothesis that Imuran can be safely tapered in most transplant patients resulting in a substantial reduction in the complications of long-term immunosuppression.